A Clinical Indications Prediction (CLIP) Scale for Human Mesenchymal Stem Cells

Project Summary
Mesenchymal stem/stromal cells (MSCs) are under intensive investigation as therapeutics for treating a diverse
array of human diseases, and while some trials have demonstrated significant patient benefits, most have yielded
suboptimal outcomes. Currently, most clinical trials employ similar manufacturing schemes to treat medically
unrelated diseases, which reflects knowledge gaps in the critical quality attributes that confer potency and
undervalues the impacts of donor selection and manufacturing on potency. We previously identified TWIST1 as
a biomarker that quantifies inter-donor differences in stem/progenitor (growth, CFU-F activity, tri-lineage
potential) and paracrine (pro-angiogenic, anti-inflammatory, immuno-modulatory) functions of MSCs, thereby
linking these functions mechanistically. We then developed a Clinical Indications Prediction (CLIP) scale based
on TWIST1 that predicts inter-donor differences in MSC potency for a range of activities to produce MSC
products tailored to specific disease indications or patient populations. Most recently, we showed that TWIST1
levels correlate with donor stature, that MSCs from short statured donors exhibit poor growth and potent immuno-
modulatory activity, and that cGMP manufacturing platforms are biased against these donor populations. Based
on these findings, the central goals of this application are to further refine the CLIP scale and establish it as an
industry wide platform to inform donor selection and manufacturing processes to produce MSC-based
therapeutics of defined potency. To accomplish these goals, aim 1 will delineate epigenetic mechanisms that
confer inter-donor differences in TWIST1 levels and correlate outcomes with donor stature to establish stature
as a critical quality attribute that confers potency. MSCs from donors of varying stature will also be exposed to
agents that license pro-angiogenic (FGF2), anti-inflammatory (IL1, TNF) and immuno-modulatory (IFNG)
activities and their impacts on TWIST1 expression will be quantified to determine if the CLIP scale predicts their
sensitivity to these agents. These data will establish the importance of donor selection on MSC potency, which
to date has been largely overlooked. Aim 2 will subject MSCs from donors of variable stature to large-scale
expansion using standard (academic) and proprietary (industry) cGMP manufacturing platforms and quantify
impacts on potency pre- and post-manufacturing using well-established pre-clinical models. Methods (small
molecules, gene editing) to modulate TWIST1 levels post-manufacturing to alter potency will also be explored.
By revealing how biases in donor selection/manufacturing impact product potency these studies will highlight
limitations of current manufacturing platforms that reduce MSC therapeutic efficacy. Lastly, aim 3 will determine
if the CLIP scale predicts inter-donor differences in MSC-derived extracellular vesicle (EV) biogenesis, cargo
content, and potency. Expanding the CLIP scale to EVs will provide a platform to guide their manufacturing as
they enter clinical testing. Successful completion of these studies will deliver a robust, industry-wide platform to
produce MSC therapeutics of defined potency for treating specific disease indications.

Public health relevance
Project Narrative Despite extensive clinical testing, mesenchymal stem/stromal cell (MSC)-based therapies continue to yield suboptimal patient outcomes due to knowledge gaps in quality attributes that confer therapeutic efficacy, which explains why most clinical studies produce MSCs using similar donor selection and manufacturing processes to treat medically unrelated diseases. To address this problem, we developed a CLinical Indications Prediction (CLIP) scale that predicts inter-donor differences in MSC potency for a range of clinically relevant activities. Building on this discovery, in this proposal we propose to use the CLIP scale to interrogate how donor selection and academic and industry-based manufacturing platforms impact MSC product potency and use this information to produce products of defined potency that are tailored for specific disease indications to enhance their efficacy.